Modeling Longitudinal Reading Comprehension in Adolescence: Protective and Risk Factors

Project Summary/Abstract
Today's high school students are required to understand and synthesize information from increasingly
complex, diverse texts. These advanced reading comprehension demands are reflected in current educational
standards, such as the Common Core State Standards, and in the English Language Arts curricula adopted by
high schools. Students are expected to `integrate and interpret' and to `reflect and evaluate' information across
text types, content areas, and presentation media. The problem is that we do not have empirically validated
theoretical models that reflect the text and task complexities encountered by high school students. Further,
extant models do not provide an explanatory framework for the advantage for monolingual over bilingual or
female over male students. This lack of evidenced-based models of the structure of reading comprehension
constitutes a critical gap in reading science that limits our ability to address the well-documented reading
deficits of high school students in the U.S. A second critical gap is the lack of comprehensive predictor
models that go beyond the simple view of reading (SVR) and consider additional cognitive influences on
reading comprehension, such as executive function, as well as psychological and ecological factors, such as
motivation and the school environment, which may become more influential as they consolidate or change
during adolescence. A third critical gap is the lack of longitudinal studies from middle to high school that can
identify unique factors operating over time that may protect adolescents from, or place them at higher risk of,
poor reading comprehension. These may differ in their strength of influence from those affecting reading
comprehension in elementary school students. Our project - Modelling Longitudinal Reading
Comprehension in Adolescence: Protective and Risk Factors - brings together multidisciplinary
researchers to address these knowledge gaps and advance understanding of reading comprehension in high-
school students. Our principal goals are to determine the structure of reading comprehension in 11th grade,
clarify key predictors of reading comprehension within and across adolescence, and to identify protective and
risk factors for good and poor reading comprehension. We build on our research conducted as the Language
and Reading Research Consortium (LARRC) and the Monolingual and Bilingual Reading Comprehension
(MBRC) project. This is a unique opportunity to continue our LARRC longitudinal study of students who
entered preschool as monolingual English speakers or as Spanish-English bilingual speakers. These two
longitudinal groups are now in 9th grade. Additional longitudinal participants from MBRC (monolingual,
bilingual) assessed in 6th grade will continue in 9th and 11th grades. We will assess these four longitudinal
samples in 11th grade, and a new cross-sectional sample of 11th graders.

Public health relevance
PROJECT NARRATIVE Our project entitled `Modelling Longitudinal Reading Comprehension in Adolescence: Protective and Risk Factors' brings together multidisciplinary researchers to advance our understanding of reading comprehension in adolescents and how reading comprehension changes over time. Our overarching goals are to determine the structure of reading comprehension in 11th grade, clarify key predictors of reading comprehension within and across adolescence, and to identify protective and risk factors for good and poor reading comprehension.